Intrinsic and extrinsic control of epithelial tissue stem cell activity

PROJECT SUMMARY/ABSTRACT
The goal of this supplemental application is to request funding to purchase a new instrument (cryostat).
The original Summary/Abstract document has not changed as a result of the proposed supplement activity.

Public health relevance
PROJECT NARRATIVE The goal of this supplemental application is to request funding to purchase a new instrument (cryostat). The original Narrative document has not changed as a result of the proposed supplement activity.